REAGENTLESS, BEAD BASED BIOSENSORS

Biotinylated fluorescent ligands are being attached to streptavidin beads, and analyzed by flow cytometry, for the purpose of developing biosensors. This project is described in detail in the year 16-20 NFCR renewal proposal. In brief, the project has three elements 1) to characterize the interaction of biotiylated ligand with strepavidin beads; 2) to detect energy transfer on the bead surface between ligands and receptors; 3) to use the energy transfer between tethered fluorescent ligands and receptors to monitor the presence of soluble ligands. 1) and 2) have been accomplished. Manuscripts for parts 1 and 2 have been accepted for publication (Buranda et al. 1999a; Buranda et al. 1999b). In the upcoming year we will take advantage of the phospholipid on bead strategy used by Nolan to further develop the biosensor. This project complements (Nolan/Swanson) in that it deals with the use of monovalent, reversible ligands rather than crosslinking reagents and detection sc hemes.